RNA-Mediated Mechanisms of Motor System Dysfunction in Spinal Muscular Atrophy

Project Summary
Spinal muscular atrophy (SMA) is an inherited neurodegenerative disease characterized by motor neuron loss
and skeletal muscle atrophy. SMA is caused by reduced levels of the SMN protein due to homozygous mutations
in the SMN1 gene and is the leading genetic cause of infant mortality. Studies in mouse models revealed that
SMA pathology involves dysfunction of sensory-motor circuits comprising multiple neuron types and possibly
non-neuronal cells. Beyond motor neuron death, dysfunction and loss of neuromuscular junctions (NMJs) as
well as central synapses from proprioceptive sensory neurons are established early drivers of motor system
pathology in SMA. Mechanistically, the SMN protein functions in the assembly of small nuclear
ribonucleoproteins (snRNPs) that mediate pre-mRNA splicing and 3’-end processing of histone mRNAs; and our
previous studies directly linked dysregulation of these RNA pathways to SMA pathology. Importantly, three
different SMN-inducing therapies have been approved for SMA treatment which prevent early death and slow
progression depending on disease severity and time of intervention. However, these therapies alone do not
provide a cure and significant motor deficits persist in SMA patients, especially those treated late. Therefore,
incomplete correction of disease symptoms combined with variability in the clinical response to treatment
represent urgent unmet needs of SMA patients. In this context, it remains essential to further our understanding
of SMA disease mechanisms as a means to identify novel therapeutic targets and to develop new
pharmacological approaches that can enhance the clinical benefit of SMN-inducing drugs through combinatorial
treatment. Here, we propose a multidisciplinary research project that addresses these outstanding issues by
building on published studies and preliminary data gathered during the previous award period. In Aim 1, we will
establish the conservation of RNA-mediated mechanisms of synaptic pathology across mouse models of SMA
with varying disease severity as a necessary step to determine their relevance to the human disease. We will
employ validated means for selective restoration of individual RNA pathways and downstream targets of SMN
deficiency by AAV9-mediated gene delivery to link the loss of proprioceptive synapses and NMJ denervation,
respectively, to disruption of U12 splicing and U7-mediated histone mRNA processing in both severe and milder
models of SMA. In Aim 2, guided by our hypothesis that dysregulation of the glutamatergic system contributes
to SMA pathology, we will determine the therapeutic potential of a novel disease-modifying pharmacological
approach aimed at stimulating glutamatergic neurotransmission and improving sensory-motor circuit activity in
mouse models of SMA. This will be tested either alone or together with SMN-inducing drugs to highlight
synergistic effects relevant for combinatorial treatment of SMA. In Aim 3, we will investigate intrinsic activation
of the innate immune response in microglia as a novel RNA-mediated, non-cell autonomous mechanism of
sensory-motor circuit pathology and a candidate therapeutic target in SMA.

Public health relevance
Project Narrative SMN-inducing therapies have been approved for the treatment of SMA, but they do not represent a cure for the disease and significant motor deficits often persist in treated individuals. The development of add-on therapies that may enhance clinical outcome is therefore highly sought after to address the urgent, unmet needs of SMA patients. Building on recent advances and preliminary data, this project aims to address this outstanding issue through the discovery of novel disease mechanisms and therapeutic targets as well as pre-clinical testing of a new pharmacological approach suitable for use in combination with SMN-inducing drugs.